Dissecting spinal interneuron circuits to augment neurological recovery in Degenerative Cervical Myelopathy (DCM)

PROJECT ABSTRACT:
This is an application for a Research Supplement to Promote Diversity in Health-Related Research for the parent
grant, “Dissecting spinal interneuron circuits to augment neurological recovery in Degenerative Cervical
Myelopathy (DCM)” (R01NS134644). DCM is a debilitating neurological condition caused by progressive
compression of the spinal cord, resulting in a wide range of devastating symptoms like loss of fine motor function,
compromised gait, sensory impairment, and chronic pain. The primary goal of the parent grant is to understand
and define the neural circuitry affected by DCM to develop strategies that improve patient functional outcomes.
The aims of the parent grant examine the anatomical and functional role of Dorsal type-3 interneurons (dI3 INs)
on forelimb function and plasticity in DCM and recovery. This diversity supplement request is for Ms. Allison
Brezinski, a highly qualified and ambitious PhD candidate whose long-term goal is to become an independent
neuroscience investigator. The research aims of this supplement examining dI3 interneurons in the role of
respiratory ability in DCM expand on the research within the parent grant and will provide Ms. Brezinski an
invaluable opportunity to lead and execute an independent research project. The training and experience
provided will hone her leadership skills while also expanding her expertise in neural circuits and neurological
disorders. Under this supplement, Ms. Brezinski will have full access to the co-investigators of the multi-
institutional parent grant to develop her networking skills and expand her scientific network for future
collaborations. Altogether, the award and completion of this supplement will be a crucial step in Ms. Brezinski’s
career and support her goal of becoming an independent academic researcher.

Public health relevance
PROJECT NARATIVE: This diversity supplement is requested to support the scientific and career training of Ms. Allison Brezinski, a promising PhD candidate whose long-term goal is to become an independent neuroscience investigator. Ms. Brezinski’s independent research project examining the role of Dorsal type-3 interneurons (dI3 INs) in respiratory circuity and recovery in degenerative cervical myelopathy expands on the parent grant’s goal of investigating dI3 INs in neural circuity and recovery of fine motor movement in DCM. The training and mentorship provided to Ms. Brezinski under this supplement will be valuable to her development as a scientist, and an instrumental step in her achieving her professional and personal goals of becoming an independent academic researcher.